Drive to Zero: Developing a digital cohort to understand the drivers of non-sustained viral suppression in the Deep South

PROJECT SUMMARY
A combination of individual-, network-, community-, and structural-level variables impact all steps in the HIV Care
Continuum, particularly in the Deep South states of Alabama (AL), Louisiana (LA), and Mississippi (MS), which
disproportionately bear the nation's HIV burden while simultaneously having the fewest healthcare resources.
While the individual-level correlates of viral suppression (VS) are well-known, few epidemiologic studies,
especially those that are digitally-based, have examined VS from a multilevel lens that accounts for the role of
geographic and community-level characteristics germane to the Deep South, such as aggregate poverty
measures, racial segregation, and healthcare access. Epidemiological studies also typically exclude people with
HIV (PWH) with non-sustained VS (non-VS) or without recent HIV labs, as these are among the hardest to
identify and reach due to their limited healthcare involvement. Our highly experienced study team will address
these research gaps through the proposed UG3-UH3 study, which will use mHealth technology to optimally
recruit, screen, enroll, and retain a prospective digital cohort of 1000 PWH in AL, LA, and MS with non-VS or
who otherwise lack evidence of having been in care for the previous 12 months, leveraging long-standing
relationships with public health departments in each of these three states. We will assemble a community
advisory board (CAB), consisting of PWH, health department partners, and HIV care team members in the three
states and we will use the Information System Research (ISR) Framework to tailor features of an existing
adherence management app for PWH, WiseApp. We will test usability of the Drive to Zero app prototype with
PWH and informaticians. Eligible cohort participants will be PWH ages ≥18 years, living in AL, LA, or MS, living
with HIV for ≥12 months, and entered in the Enhanced HIV/AIDS Reporting System (eHARS), a standardized
document-based surveillance database used by all state health departments to report diagnosis and outcomes,
with a recorded VL≥200 c/mL ≤12 months or have missing HIV lab values during that same period. Participants
will be followed for three years with iterative annual psychosocial quantitative survey assessments conducted
via the Drive to Zero app to assess predictors, mediators, and moderators for non-VS. We will contextualize
quantitative data by using geospatial analysis, linking participant residence addresses at time of enrollment to
Census tract data. Participants of the digital cohort (n=45) will also be eligible to participate in qualitative in-depth
interviews to contextualize quantitative results. The findings from this study will inform efforts to recruit large,
digital cohorts of PWH and will be among the first to demonstrate effective methods of retaining digital cohorts
for HIV as well as other health conditions. Study findings will also help identify multilevel factors that contribute
to non-VS in the Deep South, thereby elucidating future areas for intervention, and will directly lead to a follow-
up R-level application.

Public health relevance
Narrative Leveraging our previous HIV surveillance work with health departments, the goal of this study is to refine, based on community feedback, an mHealth app, WiseApp, to recruit, screen, enroll, and retain a large digital cohort of people with HIV (PWH) over age 18 years (N=1000) who have non-sustained viral suppression (nVS) or who have no evidence of HIV labs within the past 12 months. The study will be conducted in the Deep South, the area of the country with the highest rates of morbidity and mortality, including the states of Alabama, Louisiana, and Mississippi. The findings from this study will inform efforts to recruit large, digital cohorts of PWH, will be among the first to demonstrate effective methods of retaining digital cohorts for HIV as well as other health conditions, and help identify multilevel factors that contribute to nVS in the Deep South, thereby elucidating areas for intervention in future research.